Women and HIV: Translation of Research into Practice

ABSTRACT
In this 5-year renewal application for the Kenya Medical Research Institute (KEMRI) and University of
Washington (UW) program entitled, Women and HIV: Translation of Research into Practice, will continue to build
research capacity to prevent new HIV infections among women and adolescent girls in Kenya and sub-Saharan
Africa and optimize care and treatment for this high-risk, vulnerable population. To reduce incident infections
and ensure long, healthy lives for persons living with HIV, it is necessary to conduct locally relevant research
that addresses the know-do gap and informs national guidelines, clinical practice and policy. It is also essential
that communities and local health officials participate in identifying the most pressing problems and in finding
feasible, sustainable and innovative solutions to address them. The proposed training program’s primary goal is
to build capacity at KEMRI and the Kenya Ministry of Health (MOH) in implementation science focused on HIV,
women and adolescents, while creating bridges to communities of adolescent girls and young women (AGYW),
local health officials, and other organizations responsible for healthcare practice and service delivery. KEMRI’s
strong commitment to conducting research that informs service delivery and improves national health outcomes
in Kenya provides a strong foundation for the program, which will continue to be led by Drs. Carey Farquhar and
Elizabeth Bukusi. Dr. Farquhar is a UW Professor of Global Health, Medicine, and Epidemiology recently
appointed Vice Dean for Education in the School of Public Health. Dr. Bukusi is a Chief Research Officer at
KEMRI who trained as an obstetrician-gynecologist and epidemiologist, earning her MPH and PhD at UW. The
first aim builds on the successful first 4 years of the training program. Seven Kenyans received support for long-
term training during this period: 4 MPH, 2 PhD, and 1 MPH/PhD. In addition, 5 trainees completed medium-
term, non-degree training at UW. In the next 5 years, we propose to fund more doctoral level training in-country,
supporting 6 trainees from KEMRI or MOH to pursue a PhD in implementation science at the University of
Nairobi. To ensure a pipeline of candidates, we will also support 5 MPH trainees at UW and 5 year-long certificate
trainees who will be based primarily in Kenya and take 1 month of coursework in Seattle, followed by workshops
and UW distance-learning courses in Kenya. The third aim will extend the reach of training to a greater number
of KEMRI and MOH staff by providing 1-week courses on implementation science, grant writing, and manuscript
preparation. Conferences that bring together members of the AGYW community with KEMRI and MOH
researchers and county health directors will be offered to promote community engagement in local care,
treatment and prevention in Western Kenya, where adolescents and women are at unacceptably high risk for
HIV. Using UW’s well-established approaches to training, this program will establish greatly needed
implementation science research capacity at KEMRI and MOH, and contribute to changing the face of the HIV
epidemic in Kenya.

Public health relevance
NARRATIVE The proposed program will train researchers at the Kenya Medical Research Institute (KEMRI) and the Ministry of Health (MOH) to conduct locally relevant research that will improve the lives of adolescent girls and women affected by HIV in Kenya and other parts of sub-Saharan Africa. Research will be focused on finding ways to implement interventions that have been proven to work and can directly lead to changes in guidelines, clinical practices and policies. Building capacity at KEMRI and MOH to conduct implementation research will have a long-term benefit for girls and women at highest risk for HIV acquisition.